Unfolding the Link Between the Endoplasmic Reticulum, AIS Shortening, and Cognitive Impairment in Type 2 Diabetes

Project Summary/Abstract
The axon initial segment (AIS) is a critical mediator of neuronal function, and changes in its structure or
location have been implicated in several neurodegenerative conditions. In diseases such as diabetes and
Alzheimer's disease, there is a shortening of the AIS with cognitive impairment. Dementia and mild cognitive
impairment are well recognized comorbidities of type 2 diabetes, termed diabetic encephalopathy, that lack in
course modifying treatment options. AIS shortening may be reversible, hence investigating the mechanism
responsible could address this significant gap in patient care by providing new therapeutic targets. The overall
goal of this proposal is to examine the cellular mechanisms responsible for AIS shortening in these patients
while providing the training necessary to support the career development of the applicant. Endoplasmic
reticulum (ER) stress, a cellular condition that activates the unfolded protein response (UPR) has been
implicated in diabetic encephalopathy. Preliminary studies show induction of ER stress induces AIS shortening,
and inhibition of ER stress prevents AIS shortening in vitro. This NRSA F30 proposal will test the hypothesis
that endoplasmic reticulum stress modulates the axon initial segment leading to cognitive impairment in type 2
diabetes utilizing two aims. Aim 1 will test the hypothesis that the UPR PERK pathway underlies ER stress-
induced AIS shortening. The PERK pathway of the UPR activates calcineurin, a phosphatase associated with
AIS shortening. This aim will pharmacologically and genetically inhibit PERK in mouse cortical neuron culture
and evaluate changes in AIS structure and neuronal network activity following ER stress induction. Aim 2 will
test the hypothesis that ER stress inhibition ameliorates AIS shortening and cognitive impairment in diabetes.
This aim will inhibit ER stress in db/db mice, an established model of type 2 diabetes, and evaluate changes in
cognitive performance and AIS structure. Confirmation of the central hypothesis in the proposed study will
identify ER stress and AIS shortening as therapeutic targets to mitigate cognitive impairment in diabetic
encephalopathy. Completion of this proposal will also provide opportunities for training key to the applicant's
future research goal to be an independent physician scientist studying changes in neural transmission and
cognitive defects caused by neurodegenerative diseases. This proposal is significant because completion will
elucidate a target for therapeutic research to treat this condition in patients with type 2 diabetes while training a
future physician scientist who will care for them.

Public health relevance
Project Narrative Changes in the length or location of the axon initial segment in neurons has been implicated in many neurodegenerative conditions including type 2 diabetes. This application will uncover the role of endoplasmic reticulum stress in type 2 diabetes induced AIS shortening and cognitive impairment while training a future physician scientist. Completion of the proposed research will impact public health by providing important fundamental knowledge of the pathophysiology of diabetic encephalopathy that can be used in future studies to develop treatments for the patients living with these conditions.